The structural underpinnings of disinhibition in dystonia

PROJECT SUMMARY / ABSTRACT
Dystonia is a brain-based disorder that leads affected muscles to twist and spasm, contorting the sufferer
into painful and disabling positions. Dystonia afflicts 1 in 1000 people (the third-most common movement
disorder). It can occur in isolation or be a symptom of many other neurological disorders (eg, stroke, cerebral
palsy, Parkinson disease). Chronic pain, disability, and withdrawal from school or work are common, and in
severe cases, dystonia can be fatal. A shared electrophysiologic abnormality links many types of dystonia:
local and long-range disinhibition. This led to the hypothesis that impaired inhibition, and a related finding,
poorly-refined sensory feedback, leads to abnormal co-contraction of agonist and antagonist muscles,
producing the contorting movements of dystonia. However, impaired inhibition is only one step in a mechanistic
cascade that leads to dystonia – the underlying structural abnormalities that produce disinhibition are unknown.
Structural abnormalities in neurological disorders point the way to improved therapies. This proposal will use
MRI to investigate brain regions that are potential anatomical substrates for impaired inhibition, with a larger
goal of identifying new targets for dystonia treatment and prevention. We will address two key gaps in current
dystonia knowledge: 1) the role of interhemispheric projections in regulating cortical motor activity (long-range
disinhibition); 2) the role of the striatal compartments, striosome and matrix, in inhibiting unwanted movements.
The study will employ novel structural, diffusion, and functional MRI techniques in two dystonia patient cohorts:
we will carry out our imaging assessments in the most common forms in adults, cervical dystonia, and children,
limb dystonia. These clinically-distinct populations will help determine which abnormalities are shared
(mechanisms generalizable to other dystonias) and which are specific to certain types of dystonia.
The mission of this Mentored Career Development Award is to seek fundamental knowledge about the
brain’s inhibitory control of movement, and to use that knowledge to reduce the burden of dystonia. This goal
parallels that of the National Institute of Neurological Disorders and Stroke: to investigate the neural
mechanisms of sensory and motor circuits that can be compromised by disease. The proposal is tailored to my
educational and training needs, ensuring that I will be prepared to succeed as an independent investigator
utilizing the tools of systems neuroscience. With this award, I will gain essential training in: 1) biostatistics and
network assessment tools such as principal component analysis, graph theoretical analysis, and causal
inference modeling; 2) the experimental design and implementation of functional MRI (fMRI), including both
task-based and resting state methods; 3) knowledge of the structure and connectivity of the striatum, pallidum,
and thalamus. I will benefit from an environment enriched in neuroimaging, movement disorders, and
neurodevelopmental expertise, where I can build a substantial foundation for a successful independent
research career devoted to improving the therapies available for treating dystonia.

Public health relevance
PROJECT NARRATIVE Dystonia is a movement disorder in which muscles twist and contort, forcing patients into painful and disabling postures and abnormal positions. The brain changes that lead to dystonia are largely unknown, but may result from failure of inhibitory mechanisms to keep muscle activity in check. We will perform brain MRI scans to identify the structural changes associated with dystonia, which is an essential step to developing more and better treatments for this disabling movement disorder.